Structure and Pharmacologic Modulation of the Mitotic Chromosome's Central Axis

Project Summary
Mitotic chromosome formation is essential for the dissemination of genetic information in eukaryotes.
The conversion of dispersed interphase chromatin into the iconic, X-shaped metaphase chromosome
involves three principal events: the formation of a central axis (the chromosomal “scaffold”), lengthwise
contraction, and condensation. Plausible theories have been advanced to explain the latter two events,
with contraction occurring through the extrusion of chromatin loops and condensation occurring through
a volume phase transition of the chromosomal material. In contrast, little is known about the formation
of the mitotic scaffold, and its very existence has been the source of considerable controversy. Direct
evidence for the scaffold's existence has recently come from the observation of a central filament in
native mitotic chromosomes subjected to controlled expansion ex vivo. This filament could be liberated,
intact, from its chromosomal confines by careful nucleolysis, providing a basis for further study.
This proposal aims to elucidate basic principles of the mitotic chromosome scaffold, including its
molecular composition (Aim 1), its three-dimensional architecture (Aim 2), and its interactions with the
chromatin enveloping it (Aims 1 and 2). The information obtained will provide a global view of the
core of the mitotic chromosome, explaining how its components assemble into a structure of mesoscopic proportions and how this structure organizes the genome in a manner ensuring its faithful and
efficient distribution. The acquired knowledge will enable more detailed investigations into the mechanisms governing scaffold assembly and disassembly and the nature of its interactions with other cellular
components (e.g., chromatin, kinetochores).
This proposal also seeks to develop chemical modulators of scaffold assembly (Aim 3). As the
scaffold and its constituents are increasingly understood to play important roles in human health and
disease, such tools will not only enable further research on the scaffold but will also allow for its pharmacological manipulation in clinical contexts. Dysregulation of scaffold components such as the condensins, for instance, has been implicated in a growing number of malignancies, where they contribute
to a particular form of genome instability known as chromosome instability. Genome instability is a key
factor in the evolution of cancer cells, facilitating their escape from immune clearance and their acquisition of therapeutic resistance. By suppressing a pathway leading to chromosome instability, modulators
of condensins (and other scaffold components) may act to limit the evolutionary potential of cancer
cells.

Public health relevance
Project Narrative Little is known about the axial core, or “scaffold,” of the mitotic chromosome, and until recently its very existence was in doubt. This proposal aims to establish basic principles of scaffold organization and to develop tools for modulating scaffold assembly and function. Such tools will provide the basis for phar- macological inhibition of scaffold formation, enabling the targeting of cancer cells in a mechanistically novel manner.